The molecular basis of synaptic specificity

PROJECT SUMMARY/ABSTRACT
The long-term objective of our studies is to understand the molecular mechanisms underlying the formation of
synaptic connections between neurons in the brain. These patterns are complex and highly specific and they
represent the genetic hardwiring of behavior. Extensive maps of connections between neurons have been
assembled in Drosophila melanogaster. These maps of unprecedented completeness provide an extraordinary
opportunity to leverage the molecular and genetic toolkit in Drosophila and the dramatic advances in light
microscopy to uncover the logic and mechanistic basis for the formation of the connectome. Here we focus on
the development of specific patterns of connections in the Drosophila visual system. We focus on how different
synapses form in different domains of the same dendrite and how neurons select between different potential
synaptic partners. Specific proteins will be tagged in cell-type specific ways allowing for precise subcellular
resolution of protein distribution. The precise localization of proteins to specific synapses is facilitated by imaging
isotropically expanded tissue using light-sheet microscopy. Synapse associated proteins are identified in
complexes associated with tagged neurotransmitter receptors using an affinity purification-mass spectrometry
workflow. This proposal seeks to close the gap between cell recognition molecules mediating interactions
between developing axons and dendrites and the precise patterns of synapses between neurons. We explore
this relationship by focusing on cell recognition molecules which allow developing processes of different axons
and dendrites to discriminate between one another and protein complexes comprising different neurotransmitter
receptor subunits and associated proteins at synapses within specific dendritic spatial domains. The specific
aims of this project are: 1. Uncovering the molecular basis of synaptic specificity at GluClα synapses in the distal
domain of T4 dendrites. These studies will focus on Mmd, a fly homolog of a mammalian synaptic adhesion
molecule Adam22 and other GluClα-associated proteins; 2. Uncovering the molecular basis of synaptic
specificity at nAChRα5-containing synapses in the central domain of T4 dendrites. These studies will focus on
Side-VI protein, a synapse-specificity related protein, and other AChRα5-associated proteins; and 3. Uncovering
the molecular basis of synaptic specificity at Rdl-containing synapses in the proximal domain of T4 dendrites.
These studies will focus on the role of the Turtle (Tutl) protein, a fly homolog of mammalian Igsf9b, a synaptic
adhesion protein selective for GABAergic synapses. It will also explore other proteins associated with Rdl. These
studies will provide fundamental insights into the molecular logic and mechanisms regulating the formation of
connections between neurons. As disruption of connectivity plays a central role in neurological and psychiatric
disorders these studies provide a basis for the development of effective therapies in the future.

Public health relevance
PROJECT NARRATIVE This research will contribute to fundamental knowledge of how neurons form specific patterns of synaptic connections. Abnormalities in the development and function of synaptic connections between neurons underlie the pathology of human neurological and psychiatric disorders including, but not limited to, epilepsy, schizophrenia and autism. A deeper understanding of the fundamental mechanisms underlying the development of synapses will provide a foundation for ways to treat these disorders in the future.